Transcriptional Determinants of the Fate Trajectories of Single Human Glial Progenitor Cells in Response to Demyelination in Vivo

Abstract
In this application, we will test a longstanding but effectively untested hypothesis in myelin biology, that
white matter recovery after sustained or recurrent demyelination might be constrained by the finite mitotic
competence of the human glial progenitor cell pool. Such a mobilization-dependent depletion of mitotically-
competent progenitors might lead to mitotic senescence, and hence to the eventual failure of remyelination noted
in progressive multiple sclerosis. In addition, any such depletion of competent progenitor cells might also be
expected to limit the utility of differentiation-based approaches towards induced remyelination. We thus propose
to assess the responses of human glial progenitor cells (hGPCs) to demyelination in vivo, by defining the single
cell RNA expression patterns of hGPCs, both at baseline and in response to sustained cuprizone demyelination
in vivo. To this end, we will use mice neonatally chimerized with human GPCs, a novel model we have developed
in which mouse oligodendrocytes and astrocytes are largely replaced by their human counterparts in vivo. Using
these human glial chimeras, we will ask the following questions: 1) What is the phenotypic and transcriptional
heterogeneity among single human glial progenitor cells in vivo, in the otherwise undisturbed adult glial chimeric
brain? Are all GPCs multi-lineage competent? Are some more restricted than others to astrocytic or
oligodendrocytic fate? Are some in cell cycle while others are more quiescent? How do these phenotypic
distributions change with age? 2) How heterogeneous are the transcriptional responses of resident human GPCs
to demyelination in vivo? In response to cuprizone-mediated demyelination, what differentially regulated
pathways distinguish quiescent, initially mobilized, and actively remyelinating hGPCs? These experiments will
combine the use of human glial chimeras engrafted with genetically tagged GFP+ hGPCs, with later single cell
RNA-seq of both the post-demyelination white matter, and of pooled hGPC isolates after post-demyelination
FACS, to define the transcriptional events associated with human GPC mobilization and remyelination in vivo.
3) Does the efficiency of remyelination by hGPCs fall with sustained demyelination? Are human GPCs capable
of self-renewal during sustained demyelination, or is remyelination delimited by their mitotic senescence? These
experiments will assess both methylation state and telomeric length of GPCs in vivo, both before and after
sustained cuprizone exposure, so as to define the effects of sustained demyelination on these hallmarks of
cellular aging. In addition, we will assess the transcriptional concomitants to methylation state-defined aging, by
RNA-seq of the same cells as a function of time after demyelination. By this means, we intend to define both the
transcriptional hallmarks of mitotic exhaustion by hGPCs, and the epigenetic correlates to that process, and by
doing so to identify therapeutic targets by which to delay or control the demyelination-associated depletion of
mitotically-competent hGPCs.

Public health relevance
Project Narrative Glial progenitor cells pervade the adult human brain, and can give rise to new oligodendrocytes in response to demyelination; yet they often fail to do so in progressive multiple sclerosis and other conditions of diffuse or recurrent demyelination. Our goal with this work is to identify the basis for the loss of progenitor cell competence that accompanies the terminal failure to remyelinate that characterizes longstanding MS. We will do so by subjecting humanized glial chimeric mice to recurrent demyelination, and then using a combination of single cell RNA analysis, deep mRNA/miRNA sequencing of sorted populations, and methylation state and telomeric length-defined assessment of cell aging, to define the regulatory control of fate determination by demyelination- mobilized human glial progenitor cells, both vivo and in real time.